Disability Community Engagement Partner Project

The All of Us Research Program (AoURP) is a project through NIH with the purpose of advancing precision medicine. The project aims to enroll 1 million or more people in a longitudinal biomedical research study. This goal includes all of the American people, including those who have responded to any of the ACS-6 questions. Therefore, the American Association on Health & Disability (AAHD) is supporting this effort through facilitated enrollment activities, retention and recontact efforts, supporting relevant Partnered Research Studies and the broader NIH program with overall awareness and competency resources and providing other technical assistance to the All of Us Research Program.

Public health relevance
Given the overarching goal of the AoURP to improve health to advanced biomedical research for American people, AAHD is actively working to advance public health and biomedical research with the goal of reducing mortality and improving health and well-being of the American people.